Pediatric musculOskeletal & RheumaTology Innovation COre center (PORTICO)

ABSTRACT/PROJECT SUMMARY - OVERALL COMPONENT
Children with pediatric rheumatic and non-inflammatory musculoskeletal diseases (PMSKD) have an urgent
need for evidence-based medical care that considers the striking differences between pediatric and adult
populations. To address these gaps in scientific knowledge, we propose to establish a Pediatric musculOskeletal
& RheumaTology Innovation COre center (PORTICO) at the Cincinnati Children' Hospital Medical Center.
Objectives of PORTICO will be to promote impactful research in PMSKD, locally and nationally, with a focus on
our well-established research programs in juvenile arthritis, lupus and juvenile fibromyalgia. Specific Aims are:
Aim 1: To promote innovation and support clinical research with advanced data science, data analytics
capabilities, and data pipeline development.
Aim 2: To invigorate cross-disciplinary team science of the local but also national community of researchers in
PMSKD.
Aim 3: To enhance research in PMSKD by developing and offering cutting-edge assessment tools for capturing
the benefits of health interventions and delineating PMSKD phenotypes. Advanced imaging services to support
PMSKD research (ultrasonography, magnetic resonance imaging, biomechanical assessment) will be
provided, new imaging-based methods and scoring systems developed and an interactive dashboards to
synthesize information from patient reported assessments, imaging data, novel biomarkers and traditional
disease measures developed in support of improved shared medical decision making.
Expected result: PORTICO will create a vibrant research environment that fosters productive team science to
find answers to important scientific unknowns regarding PMKSD. Innovation will be sought by (1) developing
diagnostics for PMSKD (laboratory tests, imaging tests) and testing their integration into clinical care, and (2)
advancing evidence-based based therapies, with focus on JIA, cSLE and JFM. Spread of PORTICO findings
and increase of the local & national Research Community will be achieved by multisite research studies,
PORTICO's Outreach Program, and its Pilot & Feasibility Studies Program. Alignment with the efforts of other
CCCRs, other organizations involved in PMSKD research, and the local research environment is anticipated to
potentiate spread of ideas and innovation by PORTICO investigators

Public health relevance
PROJECT NARRATIVE - OVERALL COMPONENT The Core Center for Clinical Research at the Cincinnati Children's Hospital Medical Center, the Pediatric musculoskeletal & RheumaTology Innovation COre center (PORTICO), consists of an Administrative Core, a Methodology Core, and a Patient Assessment Resource Core which will support studies using imaging and advanced patient-reported outcomes measurement. The investigations of the Research Community are mainly in pediatric musculoskeletal diseases (PMSKD), particularly juvenile idiopathic arthritis, childhood-onset lupus, and juvenile-onset fibromyalgia. The focus of PORTICO is the advancement of developmentally-appropriate cutting-edge diagnostic tests and response measures that better capture the patient perspective and impact of disease and therapy. We will also study innovative treatment approaches that are tailored to each child's needs. PORTICO's research innovation is anticipated to yield improved disease control, better health-related quality of life of children with PMSKD; less disease damage, lower long-term disability and societal cost.